Research Measures, Methods and Data Management Core

Project Summary- Research Methods, Measures, and Data Management Core
The Research Methods, Measures, and Data Management (RMMDM) Core will advance the goal of the
WashU-ACCERT center, to advance cancer control equity through community-engaged multilevel (individual,
community, system, and structural) research interventions that address the impact of social determinants of
health (access, affordability, availability, accessibility, accommodation, and acceptability) on adverse cancer
control outcomes, through three main functions. First, we provide distinct support in design, measures, and
methods for the Community Responsive Research Program (CRRP) which includes the main Social
Determinants of Health intervention and community responsive projects within the Center. Second, the
RMMDM Core is also responsible for supporting and administering Community Responsive Projects in the
ACCERT Center. This includes engaging community partners in the selection, development, and adaptation of
measures, as well as ensuring data sharing has community relevance and unintended consequences of data
collection is monitored. RMMDM will work closely with the CRRP on administering community responsive
projects including, solicitation of projects, review and engagement with project leaders, and reporting back on
progress, lessons learned, and outcomes to community. We have also identified measures and a process to
evaluate community engagement across the center which will be implemented with collaboration with the
Administrative Core. Third we bring expertise in data management, data analysis methods for multilevel
interventions, reporting of results, dissemination of research results through appropriate channels, and data
sharing.
The Aims for the Core are:
1. To provide distinct design, methods, measures, and related support for the CRRP and the SDOH multi-
level trial within the Center.
2. To engage community members in the development and adaptation of measures and support and
administer Community Responsive Research Program in the ACCERT Center.
3. Manage study data, analyses and prepare data summaries for scientific and community reporting,
guide dissemination of results and support data sharing requirements for the CRRP and SDOH and
cross center studies within our Center.
Building on strengths of Siteman Cancer Center's Biostatistics and Qualitative Research Shared resource we
bring rich and diverse quantitative and qualitative skills to support community driven trials.